Cancer Research Career Enhancement and Related Activities

CANCER RESEARCH CAREER ENHANCEMENT AND RELATED ACTIVITIES
PROJECT SUMMARY/ABSTRACT
Cancer Research Career Enhancement and Related Activities are essential to a National Cancer Institute
(NCI)-designated Comprehensive Cancer Center and important to foster transdisciplinary
collaborations. Education/Career Enhancement programs at the Rutgers Cancer Institute of New Jersey
(CINJ) span the continuum from middle school through postgraduate education with career enhancement
continuing to include faculty. They include the development of innovative programs tied to CINJ Program
science including programs that focus on the underserved in our community. Developed by and/or coordinated
with the CINJ Office of Education and Training, programs have grown in scope and number over the last
funding period, spurred by the overall growth of CINJ research Programs, the integration of the University of
Medicine and Dentistry of New Jersey (UMDNJ) into Rutgers University, and the continued development of the
CINJ consortium with Princeton University. We plan to enhance and expand on our complementary series of
established research and career-enhancing programs to further: 1) develop and implement programs that
leverage the strengths of CINJ in training the next generation of basic, clinical, and population researchers and
the broad-based student population; 2) provide CINJ supported seminars, conferences, and retreats to impart
the most up-to-date information for the education of trainees, faculty, and the community across our catchment
area and beyond; and 3) provide state-of-the-art career enhancement opportunities to CINJ junior faculty.
!